Project 2: Role of ACER2 in Liver Cancer

Abstract
Hepatocellular carcinoma (HCC), a major type of liver cancer, is a leading cause of cancer deaths worldwide.
HCC remains refractory to most treatment options; hence, new therapeutic modalities are urgently needed. Our
long-term goal is to develop novel HCC therapeutics based on a deep understanding of its pathogenesis. The
specific goal of this application is to define a novel tumor suppressive role for the alkaline ceramidase 2
(ACER2) pathway in HCC development and progression. ACER2 is a member in the alkaline ceramidase family
that we identified initially from the yeast Saccharomyces cerevisiae and then from mammals. ACER2 catalyzes
the hydrolysis of ceramides to generate sphingosine (SPH), a bioactive lipid implicated in programmed cell death
(PCD) and autophagy. We identify ACER2 as a novel transcriptional target of p53 and demonstrate that the
ACER2/SPH pathway is a novel signaling axis that operates downstream of p53 to mediate PCD in response to
DNA damage. According to the TCGA database, ACER2 is mutated or deleted suppressed in several cancers.
A previous study finds that ACER2 is epigenetically repressed in HCC and our preliminary results reveal that
ACER2 is downregulated in liver tumors compared to patient-matched adjacent non-tumor liver tissues.
Remarkably, we find that mice deficient in the alkaline ceramidase 2 (Acer2) gene are more susceptible to age-
related development of various spontaneous tumor types including liver tumors, suggesting that ACER2 is a
novel tumor suppressor. According to these exciting findings, we hypothesize that ACER2 is a novel tumor
suppressor whose suppression promotes HCC development, progression, and resistance to DNA-damaging
chemotherapeutics. As a further corollary, we hypothesize that rectifying the ACER2/SPH pathway will inhibit
HCC and overcome the resistance of HCC to chemotherapeutics. These hypotheses will be tested in three
interrelated specific aims: Aim 1 Establish that ACER2 plays a key tumor suppressive role in HCC using a liver
carcinogenesis mouse model and liver organoid model, Aim 2 Define the cellular and molecular mechanisms by
which the repression of the ACER2/SPH pathway promotes liver tumorigenesis, and Aim 3 Establish the role of
the ACER2 pathway in improving the radio/chemotherapy of HCC. Successful completion of these aims will 1)
validate the tumor suppressive role of the newly-identified tumor suppressor ACER2; 2) offer novel insights into
the mechanisms by which the newly identified p53/ACER2/SPH signaling axis mediates the DNA damage
response and tumor suppression; and 3) provide a proof of concept to develop the ACER2/SPH pathway into a
novel therapeutic target for HCC. Given the poor clinical outcome of patients with HCC, these studies may have
widespread impact on the clinical management of these patients.

Public health relevance
Narrative Liver cancer is a leading cause of cancer deaths worldwide. Liver cancer remains refractory to many treatment options; hence, new therapeutic modalities are urgently needed. The specific goal of this application is to investigate how the alkaline ceramidase 2 gene (ACER2), a newly identified tumor suppressor gene, suppresses liver cancer development and progression and whether increasing its expression can boost liver cancer chemotherapy.